Examining the re-use and specialization of an organ-forming gene regulatory network

PROJECT SUMMARY
The goal of this research is to examine how gene networks are re-used and specialized
to generate repeated organs in the body, such as hairs, neurons, or muscles. Gene regulatory
networks are assemblages of genes that transcriptionally regulate one another. These networks
govern which proteins are produced in a cell to derive its own unique physical properties such as
size, shape, or color. We have known for some time that many networks are re-used during
development to generate various types of repeated organs across the body. This makes sense,
as it would be much faster to re-use an existing network rather than completely build one from
scratch. However, we have very few model systems in which the specifics of gene regulatory
network re-usage can be studied. Experimental systems in which the usage of a network can be
induced are particularly powerful for investigating how this process works.
A second related problem is that of specialization. While repeated organs share many
commonalities, it is the differences between them that we would often like to understand. How is
a network that is used in hundreds of locations across the body individualized to generate a
position-specific morphology?
Here, we will examine a gene regulatory network that has been re-used to generate a new
set of hair organs in Drosophila. Of particular interest, these hairs are highly specialized and are
far larger than the other hairs that have been documented in this species. We have identified a
gene that was critical to the re-use of this hair-forming network, and have made the remarkable
discovery that we can induce hairs in species that lack these structures by simply activating this
gene in the right developmental tissue. This finding led us to propose an exploratory set of
experiments that will rapidly illuminate how this gene regulatory network was re-used and
specialized: (A) We will examine the expression of genes known to be part of the ancestral larval
hair network in the species which possesses these new highly specialized hairs. (B) We will seek
out new genes that contribute to the spectrum of diversity of hair morphologies we have observed.
(C) Using CRISPR/Cas9 and gene mis-expression technologies, we will determine whether genes
identified to be important for generating specialized hairs are required or sufficient to do so.
This research will inform the how processes of network re-use and specialization
molecularly operate, providing insights into how specific genes and cellular processes may play
roles in the regulation of organ size and shape.

Public health relevance
PROJECT NARRATIVE This research addresses how collections of genes referred to as “networks” are recurrently re- used in different parts of the organism during development to activate the formation of repeated organs, such as hairs, neurons, or muscles. We will examine how a hair-forming network was modified to generate differences in the size and shape of repeated organs in the fruit fly. This work will illuminate how networks govern differences in organ size and/or shape, providing insights into how human networks operate normally or contribute to disease.